The Role of Prohibitin 1 in Ethanol's Sensitizing Effect on Colorectal Liver Metastasis

ABSTRACT
Prohibitin 1 (PHB1) is an evolutionary conserved protein with multiple functions depending on its subcellular
location, post-translational modifications (PTMs) and interactome. Mitochondrial PHB1 is a chaperone, nuclear
PHB1 regulates gene expression. While the role of PHB1 in cancer is conflicting, our preliminary data show
nuclear and mitochondrial PHB1 exert opposing actions, with nuclear PHB1 being tumor suppressive. We
found normal hepatocyte PHB1 expression defends against colorectal liver metastasis (CRLM) as Alb-Cre
Phb1+/- mice are markedly sensitized to CRLM via induction in matrix metalloproteinase-7 (MMP-7)
transcription since the heightened sensitivity to CRLM was abolished if hepatic MMP-7 was silenced prior to
intrasplenic injection of colorectal cancer (CRC) cells. Interestingly, once CRC cells reach the liver, signal(s)
are sent out that lower hepatocytes’ PHB1 expression and increase MMP-7, which is a novel feedforward
mechanism to promote CRLM. Excessive alcohol intake increases the risk of primary cancers and CRLM in
humans and mice. Interestingly, we found in murine and human alcohol-associated liver disease a dramatic
depletion of nuclear and cytosolic PHB1 while mitochondrial PHB1 is protected, and increased MMP-7
expression. Hepatocyte nuclear PHB1 depletion is responsible for EtOH-mediated MMP-7 induction and
activated hepatic stellate cells (HSCs) and Kupffer cells (KCs) through its secretome. In the cytosol PHB1
interacts with histone deacetylase 4 (HDAC4) so depletion of cytosolic PHB1 increased HDAC4 nuclear level.
HDAC4 is implicated in cancer metastasis but its role in the sensitizing effect of ethanol (EtOH) on CRLM is
unknown. Taken together, our results support the central hypothesis that EtOH sensitizes the liver to
CRLM in part by depleting hepatocyte’s nuclear and cytosolic PHB1 pool. We will examine this central
hypothesis in four specific aims: 1. Examine mechanisms and consequences of EtOH-mediated depletion
of nuclear PHB1. Investigate whether EtOH impairs import and/or accelerates export, whether this is
mediated via altered PHB1 PTMs and/or interactome and define PHB1 target genes impacted, and how EtOH-
mediated hepatocyte nuclear PHB1 depletion activates HSCs and KCs. 2. Examine mechanisms and
consequences of EtOH-mediated depletion of cytosolic PHB1. Examine whether this is due to increased
export in extracellular vesicles (EVs), and if it leads to higher nuclear HDAC4 content and associated changes.
If so, we will examine blocking increased nuclear HDAC4 on CRLM under control and EtOH diets. 3. Examine
the role of PHB1-MMP-7 axis on EtOH’s sensitizing effect on CRLM. We will test the effect of silencing
hepatic MMP-7 on CRLM under control and EtOH diets and examine if preserving nuclear PHB1 with a specific
nuclear export peptide will protect from EtOH-induced CRLM. 4. Examine the EtOH-CRC crosstalk in
modulating hepatoyte’s PHB1-MMP-7 axis. We will determine how CRC cells lower hepatocytes’ PHB1
while increasing MMP-7 expression and how EtOH enhances this response using proteomics and RNA-Seq.

Public health relevance
PROJECT NARRATIVE Prohibitin 1 (PHB1) is a highly conserved, ubiquitously expressed protein important in cell growth and death that protects the liver against colorectal cancer metastasis. Mice with reduced hepatic PHB1 expression or fed ethanol have heightened sensitivity to develop colorectal liver metastasis; the latter may be related to depletion of hepatic nuclear and cytosolic PHB1 content. The goals of this project are to understand how ethanol influences PHB1’s expression and whether this can be targeted to protect against colorectal liver metastasis.